Training Grant in Vision Research

PROJECT SUMMARY/ABSTRACT
The Vanderbilt Vision Research Center (VVRC) request continued support for predoctoral and postdoctoral
training. This training program develops independent vision researchers through interdisciplinary training in
vision and eye research. This is made possible by the number and cohesiveness of vision and eye researchers
at Vanderbilt who maintain an exceptionally strong training record. Aggressive faculty recruiting has increased
the number and diversity of qualified mentors and the number of NEI-funded research grants. The program of
research and training covers multiple approaches and methods including everything from classic
psychophysics to cellular and molecular eye research. Individuals trained during previous grant periods have
obtained competitive postdoctoral or faculty positions through which they have established their own
independent careers in vision research. Specific program requirements for predoctoral trainees include (1) The
Visual System course team-taught by program faculty, (2) additional courses specified by the trainee's
graduate program selected from an extensive curriculum covering molecular biology, neuroscience,
perception, and engineering, (3) participation in the local Vision Training Seminar series, the invited speaker
Vision Research Seminar series, as well as department specific seminars, (4) participation in international
scientific meetings such as Association for Research in Vision & Ophthalmology, Vision Science Society, and
Society for Neuroscience, (5) participation in a Responsible Conduct of Research program, (6) preparation and
submission of an independent NRSA proposal, and (7) most importantly, research supervised by one or more
mentors. Postdoctoral trainees are required to fulfill the same requirements except (2). Trainees will be
recruited nationally with emphasis on increasing diversity. Alliances with HBCUs in Nashville such as Meharry
Medical College, Fisk University, and Tennessee State University facilitate minority recruiting.

Public health relevance
NARRATIVE This proposal seeks to renew funding for a successful and long-running program of training in vision and eye research at Vanderbilt University, built on its core elements of course work (featuring our long-running course The Vision System), world-class seminars, intense laboratory research, and, finally, training in writing and scientific presentation. During this last funding period, our trainees enjoyed high levels of productivity and placement in jobs across industry and tenure-track faculty positions. Here we outline how we plan to continue to improve our training of the next generation of vision scientists during the next 5 years.